Multidisciplinary approach to studying genomic variation on genome function and phenotype

Project Summary
The long-term goal of our laboratory is tackling a fundamental question in the field of Genetics: How do genetic
variants drive functional changes at the molecular, cellular, and phenotypic levels? In essence, we aim to unravel
the intricate consequences of genomic variation on genome function and phenotypes. This undertaking is
particularly challenging, primarily because most variants associated with phenotypes or diseases are located in
non-coding regions, indicating their likely involvement in the regulation of gene expression. The noncoding nature
of most loci introduces another layer of complexity, characterized by cell-type specificity, developmental
dynamism, residence at considerable distances from their target genes, and often a lack of conservation across
different model systems. Additional challenges arise from allelic heterogeneity and linkage disequilibrium. This
complexity forms a bottleneck, hindering progress in understanding the genetic basis of dynamic gene
expression programs crucial for specifying distinct cell types, modulating tissue homeostasis, and influencing
diseases. Our proposal builds upon past research achievements and adopts a multidisciplinary approach that
integrates cutting-edge technologies, including computational analysis, single-cell analysis, iPSC system, and
genetic screening. The objective is to create an integrative platform for systematically investigating the genetic
architecture of complex traits and the impact of genomic variation on function. Over the next five years, we plan
to thoroughly and mechanistically characterize the effects of genomic variation on genome function and
phenotypes. We will define and systematically characterize genetic dynamics profiling to explore the impact of
allelic heterogeneity on complex traits. Additionally, our proposal aims to characterize the role of genetic variants
in cellular programs relevant to human diseases by using high-content microscopy imaging. Our research holds
the promise of providing valuable insights into the dynamic landscape of genetic regulation and its profound
impact on human health and disease.

Public health relevance
Project Narrative The research program explores the impact of genetic variants on functional changes across molecular, cellular, and phenotypic levels. It focuses on understanding gene regulation and the functional consequences of noncoding variation in DNA loci associated with phenotypes. This research will provide insights into the dynamic panorama of genetic regulation and its consequential impact on human health.